Reaching Communities through the Design of Information Visualizations (ReDIVis) Toolbox for Return of COVID-19 Results

The overall goal of Reaching Communities through the Design of Information Visualizations (ReDIVis) Toolbox
for Return of COVID-19 Results (RCR) is to decrease health disparities related to COVID-19 by enabling
widespread use of culturally congruent and health literate infographics to return the results of SARS-CoV-2
diagnostic and antibody testing in a manner that supports comprehension of the results, informs decision
making, and motivates appropriate behaviors. In collaboration with our community partner, the Association to
Benefit Children, we will use a mixed-methods research design to achieve the following specific aims:
1. Advance understanding of the factors that influence comprehension and use of the results of SARS-
CoV-2 diagnostic and antibody testing in underserved and vulnerable populations.
2. Collaborate with underserved and vulnerable populations to design infographics for returning the results
of SARS-CoV-2 diagnostic and antibody testing in a format that maximizes comprehension, informs
decision making, and motivates action.
3. Develop, implement, evaluate, and disseminate the ReDIVis Toolbox for returning the results of SARS-
CoV-2 diagnostic and antibody testing.
ReDIVis Toolbox-RCR builds upon substantial preliminary work in community engagement, lay-person
science, system development and evaluation, and information visualization as well as existing infrastructure:
(a) a research cohort of Latino adults, (b) the Visualization Design Studio of the Precision in Symptom Self-
Management Center, and (c) the novel COVIDWATCHER lay-person science platform. Informed by seven public
health ethics principles, ReDIVis Toolbox-RCR research activities (focus groups, interviews, surveys,
participatory design sessions, usability testing) will result in the web-based ReDIVis Toolbox that includes: (a)
infographics in English and Spanish for returning SARS-CoV-2 test results; (b) documents to support design,
implementation, and evaluation of infographics; and (c) software to enable the creation of tailored culturally
congruent and health literate infographics. Within the defined areas of research interests in NOT-OD-20-119,
ReDIVis Toolbox-RCR directly responds to the need for SARS-CoV-2 test results templates and toolkits
designed in collaboration with communities and strategies and resources to increase use and utility of test
results. In addition, ReDIVis Toolbox-RCR research activities will advance understanding of the social, ethical,
and behavioral implications of how test results are interpreted and used; specifically, how the results influence
decision making and COVID-19 mitigation behaviors (e.g., social distancing, self-isolation, mask wearing, and
vaccination, when available). Moreover, we will interact with other RADx-UP grantees to enhance the
generalizability of the ReDIVis Toolbox.

Public health relevance
Given the alarming health disparities in the United States COVID-19 pandemic, it is critical that underserved and vulnerable populations not only receive SARS-CoV-2 tests, but that test results are provided in a manner that supports comprehension of the results, informs decision making, and motivates appropriate behaviors. The product of this project is a Toolbox to support return of test results through culturally congruent and health literate infographics.